Advanced Imaging Core

Advanced Imaging Core – Project Summary
The COBRE in Digestive & Liver Disease (CDLD) Advanced Imaging Core provides equipment, expertise and
training to CDLD investigators for state-of-the-art cell- and tissue-based imaging, including confocal, multiphoton
and super-resolution microscopy of live and fixed cells and tissues, intravital imaging and automated imaging of
histological slides. The Advanced Imaging Core houses the following major microscope systems: 1) Zeiss LSM
880 NLO multiphoton/confocal system equipped with a Coherent Chameleon multi-photon laser, Quasar spectral
detection and Airyscan super-resolution capability; 2) Olympus Fluoview FV1200 multiphoton microscope with
SpectraPhysics MaiTai DeepSee laser and silicone oil optics for intravital imaging; 3) Olympus Fluoview FV 10i
LIV live cell confocal microscope with water immersion optics; 4) Zeiss LSM 510 META confocal microscope; 5)
BD BioSciences CARV II disk-scanning confocal microscope for video-rate imaging; 6) Zeiss Axiovert 200M
widefield fluorescence microscope; and 7) Perkin-Elmer Vectra Polaris Automated Quantitative Pathology
Imaging System. Except for Vectra Polaris which is customized for histological slides, all microscopes are
equipped with environmental chambers for temperature and gas phase control to allow non-destructive 3D
imaging of living cells, tissues and organisms. Major applications include 1) live cell imaging of parameter-
sensitive fluorophores to monitor ions, electrical potentials, radical generation, pyridine nucleotide reduction,
membrane permeability, cell viability (apoptosis and necrosis), and the submicron distribution of fluorescent
proteins and other fluorescent reporters; 2) high resolution imaging of tissue sections for immunocytochemistry
and fluorescent protein distribution; 3) fluorescence resonance energy transfer (FRET) and DuoLink to
characterize and quantify interactions between specific molecules; 4) intravital microscopy to monitor
microcirculation, leukocyte margination, mitochondrial polarization and permeability, radical generation, gene
expression and other parameters in living animals; and 5) high throughput, quantitative multiplexed imaging of
conventionally and immunostained clinical and research specimens. Ancillary equipment required for specimen
preparation is also provided. Consultation and services for TEM and SEM are available through the Department
of Pathology & Laboratory Medicine. Computer workstations provide offline image processing/analysis (ImageJ
FIJI, Metamorph, IPLab and other software). Advanced Imaging Core services provide training and assistance
to promote the success of individual CDLD investigators.